Mechanisms of alpha-arrestin-mediated protein trafficking

O’Donnell, A. F., University of Pittsburgh
PROJECT SUMMARY
Cells must rapidly reorganize the membrane proteome to survive changing environments and restore
homeostasis. How does the cell ‘decide’ to relocalize or degrade a membrane protein? Cell signaling events
modify protein trafficking adaptors, which then bind selectively to membrane proteins (referred to as cargo) to
control relocalization. This cargo reshuffling restores cellular balance, and its importance is highlighted by the
cardiovascular, neurodegenerative, and metabolic diseases linked to defects in protein trafficking adaptors.
Our research focuses on a little studied class of trafficking adaptor, the a-arrestins, that are conserved across
eukaryotes. Foundational studies of a-arrestin function, including those from our lab, have defined their role in
regulating selective endocytosis of nutrient transporters in the yeast Saccharomyces cerevisiae. However,
critical gaps remain in our understanding of a-arrestins and how they regulate cellular homeostasis: How do a-
arrestins recognize cargos? What trafficking pathways are regulated by a-arrestins? How does cell signaling
control a-arrestin activity? The proposed research will address each of these knowledge gaps.
Our studies will provide a deep, mechanistic understanding of a-arrestin function in protein trafficking. Our
preliminary work suggests that a-arrestins are master regulators of protein trafficking as they control a varied
set of cargo from diverse cellular membranes, including the Golgi and endosomes. We will use innovative and
systems-level approaches to define the cargo repertoire for a-arrestins. Leveraging these new cargos, we will
use mutational scanning to define amino acid motifs needed for a-arrestin-cargo interactions. Trafficking
adaptors interact with vesicle forming proteins to mediate cargo packaging. We identified a-arrestin
interactions with the clathrin-mediated endocytosis (CME) machinery, and we will define the amino acids
needed for these associations. Excitingly, we found that a-arrestins also act as cargo selective adaptors in
clathrin-independent endocytosis (CIE), often considered a bulk endocytic route. We posit that a-arrestins
analogously couple cargo to the CIE machinery, and we will define the cargo and trafficking machinery
interfaces needed for a-arrestins to function in CIE. Further adding to a-arrestin function, we have revealed a
new role for a-arrestins in intracellular protein sorting that causes increased trafficking of cargo to the cell
surface. As we have done for other trafficking pathways, we will determine the molecular determinants needed
for a-arrestin function in intracellular sorting. Finally, given their breadth of trafficking activities, a-arrestin
functions must be controlled by cell signaling. We have defined many kinases, phosphatases, and ubiquitin
modifiers that alter a-arrestin-mediated trafficking and will now elucidate how these synergistically control a-
arrestin function and stability. In yeast, we will establish the rules that govern a-arrestin interactions, stability,
and function, which we will then apply to our longer-term studies of mammalian a-arrestins, an emerging class
of tumor suppressor.
Specific Aims Page

Public health relevance
Project Narrative Allyson F. O’Donnell University of Pittsburgh PROJECT NARRATIVE Protein trafficking adaptors control the movement of specific proteins from one membrane to another. Defects in trafficking adaptor activity are linked to neurodegenerative, cardiovascular, and metabolic diseases, making it critical to understand the function of these adaptors. Our work will provide fundamental insight into the molecular mechanisms governing the function of a-arrestins, understudied protein trafficking adaptors that have critical roles in maintaining nutrient homeostasis and cell health.